Augmenting Vocal Fold Repair Using an Optimized Lamina Propria Extracellular Matrix Derived Hydrogel

PROJECT SUMMARY
Voice impairment is the most common communication disorder with nearly 20 million people in the US reporting
symptoms of dysphonia annually. The cost of treatment and lost wages for this disorder is approaching $13
billion. The etiology of these disorders is diverse, but given their anatomic location, the vocal folds (VFs) are
susceptible to a multitude of injurious stimuli, including reflux of gastric contents, iatrogenic injury, and the
inherent trauma associated with voice production. Injury can result in altered lamina propria (LP) architecture
resulting in aberrant phonatory physiology. To date, no treatment restores the native VF extracellular matrix
(ECM) composition, structure, and function following VF injury which likely underlies suboptimal outcomes for
patients with VF scar.
Extracellular matrix derived scaffolds, if appropriately processed, can be used as resorbable and naturally
derived biomaterials with a safe record of clinical use that promote constructive tissue remodeling. Tissue-
specific ECM hydrogels are ideal for clinical application, particularly given the emerging practice and distinct
advantages of in-office procedures using minimally invasive approaches. Work from our group and others
provide promising data regarding the role of decellularized vocal fold lamina propria (VFLP-ECM) as a
therapeutic scaffold. We broadly hypothesize that VFLP-ECM will evolve into clinical practice to provide a
scaffold that promotes functional repair of the VFs. Specifically, we seek to develop an injectable vocal fold
lamina propria hydrogel (VFLP-ECMh) that will degrade over time while harnessing the stimulatory effects of the
ECM to drive vocal fold tissue remodeling.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Voice disorders are the most common communication disorder in the US with an estimated 20 million Americans each year suffering from voice-related problems. Extracellular matrix derived scaffolds have become attractive biomaterials for clinical use given their superior ability to guide healing while avoiding excessive scar tissue formation. The proposed work will develop an injectable, off-the-shelf, and vocal fold lamina propria-specific hydrogel. This hydrogel will degrade over time to direct the local host tissue response towards repair and reduction of vocal fold scar tissue.